Decoding the Mechanisms of Oxytocinergic Regulation in the Hippocamposeptal Circuit: Implications for Social Dysfunction in Alzheimer's Disease

Project Summary/Abstract
This K01 mentored training grant is designed to support Dr. Jinjing Liu in becoming an independent
investigator in the Alzheimer’s disease (AD) field. The proposal’s scientific and training goals center on the
study of the neurobiological basis of pathological social aggression in AD. Pathological social aggression
appears in 30-50% of AD patients, impacting their quality of life, causing distress for caregivers, and imposing
immense socioeconomic burden. Yet the neural mechanisms that contribute to social aggressive behavior,
particularly within the context of AD, remain largely unknown and options to treat aggression in AD patients are
limited. Under non-disease conditions, socially aggressive behavior is the result of complex signal integration
involving information about internal state (social motivation, anxiety) and social stimuli (familiarity/novelty/threat
perception). Classical lesion studies as well as more recent neurophysiological studies implicate the lateral
septum (LS) in the control of this behavior. However, we do not understand the circuit-level mechanisms, nor
do we know how AD-related pathology disrupts its function. This proposal’s overarching goal is to identify
these circuits so that we may identify therapeutic targets for social dysfunction associated with AD. Existing
literature and preliminary data support a hypothesis that AD-related pathology disrupts a specific
extrahippocampal projection (CA2 to LSi pathway) by impairing neuropeptide oxytocin (OXT) function within
this circuit. The proposed work will test this hypothesis by (1) establishing the role of the intermediate lateral
septum (LSi) as a key integrator of cognitive information coming from the hippocampus (CA2) and OXT-
sensitive inputs about internal motivation and anxiety state; (2) determining how AD-related pathology impacts
CA2LSi circuitry to disrupt the normal regulation of social aggressive behavior; and (3) exploring the
translational potential of enhanced OXT signaling in the LSi to restore circuit function and improve behavioral
outcomes. The approach is innovative and achieves technical training goals by leveraging an array of modern
neuronal recording and manipulation techniques, including Patch-seq, in combination with neural tracing and
the use of a novel optically-sensitive caged OXT reagent developed in our lab that can achieve closed-loop
spatiotemporal control over OXT release when combined with large-scale in vivo recording. The mentor team
includes experts Dr. Richard Tsien (biophysics and synaptic physiology); Dr. Arjun Masurkar (clinical
manifestations and mechanisms of AD); and Dr. György Buzsáki (systems and computational neuroscience).
Building off extensive expertise in synaptic and ion channel physiology and animal behavior Dr. Liu will pursue
this work under the guidance of her mentors to advance her long-term career goal of establishing an
independent research program studying how neuromodulation at the molecular, cellular, and systems levels
contributes to symptoms of AD.

Public health relevance
Project Narrative Pathological social aggressive behavior affects 45% of individuals with Alzheimer’s disease, and is associated with poorer quality of life, enhanced burden on caregivers, and poorer outcomes overall. The pathophysiological basis of these symptoms is unknown. By systematically mapping the ability of oxytocin-sensitive neuromodulatory circuits connecting the hippocampus to the lateral septum to control social aggressive behavior and the impact of AD-related pathology on this circuit, we explore the possibility that these devastating neuropsychiatric symptoms can be treated early in disease progression.